Neurocognitive and Neurobehavioral Mechanisms of Change following Psychological Treatment for Alcohol Use Disorder

Description: Although modestly effective treatments exist for alcohol use disorders (AUD), many individuals
relapse to heavy alcohol use after completing treatment, suggesting the need for a better understanding of
factors that contribute to successful outcomes. Whereas much of the focus in past studies has been on
identifying what treatments work for AUDs, only recently has there been a focus on why particular treatments
work, and the mechanisms by which treatment leads to changes in drinking. This focus on mechanisms of
behavior change (MOBCs) has the potential to not only allow for an accumulation of knowledge about the
process by which treatment leads to better outcomes, but also may lead to the development of new treatments
or modifications of existing treatment approaches that target empirically supported mechanisms known to lead
to change. Existing research has focused on potential mechanisms including alcohol cue reactivity, affect
regulation, and behavioral control, but these constructs have largely been tested using self-report measures,
and there is a noticeable paucity of studies that examine these mechanisms from a neurocognitive perspective.
To address this gap in knowledge, the proposed study will examine MOBC at multiple levels including self-
report, behavioral performance, and neural network engagement, with a focus on the function of the lateral and
medial frontal control networks, striatal based reward networks, and amygdala networks underlying emotional
reactivity. One hundred eighty treatment-seeking individuals with an AUD will be randomized to receive either
8 weeks of Cognitive Behavioral Treatment (CBT) or Mindfulness Based Treatment (MBT) after receiving 4
weeks of a platform treatment that focuses on enhancing motivation to change. To establish the temporal
relationship between changes in drinking and changes in these MOBCs, patients will be assessed at: (a)
baseline; (b) four weeks into treatment; (c) immediately post-treatment; and (d) 9- and 15-months post-
baseline. Self-report measures and behavioral tasks will be administered at monthly intervals during treatment;
and fMRI will be collected at baseline, and at 3, and 9-months post baseline. Relationships between changes
in drinking and changes in the proposed MOBCs will be examined using advanced mixed modeling techniques
that have been pioneered by the research team. Further, the project will leverage data collected in a separate
project examining MOBC in a non-treatment seeking sample using the same measures collected at similar
timepoints. By identifying MOBCs of CBT or MBT that differentially contribute to changes in drinking, the
proposed project will not only derive a deeper understanding of successful behavior change, but also may
inform the development of novel treatments for AUD. In addition, by identifying neurocognitive factors
predictive of successful change, it may be possible to utilize this knowledge to match specific treatments with
particular patient neurocognitive profiles.

Public health relevance
PUBLIC HEALTH RELEVANCE. Gaining an understanding of the mechanisms that lead to successful drinking behavior change during treatment for alcohol use disorders is critical for improving treatment outcomes. The current study will examine behavior change from multiple perspectives including self-report, behavioral performance, and functional neuroimaging within the context of cognitive behavioral treatment or mindfulness based treatment to identify those mechanisms that lead to reductions in drinking. Results from the proposed study may provide key mechanisms that could be targeted in future treatment studies.